Functional connectivity reconfigurations in risk for alcohol use disorders

Project Summary
An important aspect of inherited risk for alcohol use disorder (AUD) is low executive function and adaptive
behavioral control. Emerging work shows that such executive abilities are related to activity-induced changes
in brain network functional connectivity (FC). We know very little about how inherited AUD risk affects the
large-scale network FC supporting executive functions, and the small body of extant research does not study
how networks dynamically adapt to changing demands.
Our lab’s long-term goal is to understand inherited brain vulnerabilities for AUD. This application’s
objective is to determine how AUD risks affect brain network FC reconfiguration during mental state
transitions. As informed by our published preliminary findings, our central hypotheses are that (i) inherited
AUD risk involves inefficient FC reconfiguration in transitioning between extremes of cognitive and reward
engagement, and that (ii) these transitional reconfigurations relate to adaptive control in the key AUD risk
domains. Our specific aims are therefore to:
Aim 1: Determine how FC reconfiguration during transitions between cognitive engagement and low
cognitive load (“rest”) relates to AUD risk factors.
Aim 2: Determine how FC reconfiguration during transitions between alcohol-cue stimulation (“appetitive
engagement”) and rest relates to AUD risk factors.
Aim 3: Determine how FC reconfiguration relates to drinking and alcohol-related problems.
Exploratory Aims: Test for (A) joint appetitive and cognitive task network reconfiguration effects; B)
multiple mediation effects on drinking, and (C) effects related to loss of control drinking.
Our proposed work uses a novel paradigm and analyses to characterize transitions between rest and states
of cognitive control and alcohol cue exposure. The work is thus poised to discover new fundamental
knowledge about brain network interactions necessary for flexible and adaptive behavioral regulation. Such
data are critical to understanding mechanisms of AUD risk. The findings will also be used to develop
biomarkers of “disease networks” that can be monitored in treatment research for normalization, or that can
predict therapeutic response.

Public health relevance
Project Narrative Little is known about how inherited risks for alcohol use disorders (AUD) affect large scale brain networks. Moreover, all such research ignores critical periods when brain activity changes in transition to different mental states. We will determine how AUD risks impair functional network connectivity flexibility during changes in mental state—information needed to develop brain based biomarkers for prevention and treatment research.